2017 National Psoriasis Foundation Research Symposium

Abstract Psoriasis is a chronic, systemic inflammatory disease that affects the skin and often the joints and other organs. Affecting more than 8 million Americans, it is associated with lost quality of life, reduced lifespan, and a steep burden on the economy. In support of its mission to drive efforts to cure psoriatic disease and improve the lives of those affected, the National Psoriasis Foundation (NPF) engages in research towards a cure, advocacy to improve access to therapies, and both patient and professional education. In August 2017 NPF will host a scientific Research Symposium concurrently with the patient-focused National Volunteer Conference in Chicago, IL. The Research Symposium is unique for its inclusion of cross-disciplinary aspects of psoriatic disease, its level of patient engagement with researchers, and the ability for meeting outcomes to immediately impact activities of a large patient advocacy organization. The Research Symposium will bring together more than one-hundred early career researchers, established researchers, and patients for four scientific sessions on the fundamentals of psoriatic disease and cutting-edge research results, a poster session open to a combined patient and research audience, and discussion sessions focused on optimizing NPF's role in supporting psoriatic disease research. The Research Symposium venue will facilitate access from interested individuals from around the world and foster networking and collaboration between researchers across disciplines and career stages. Outcomes from the Research Symposium will be disseminated to both patient and professional audiences through both digital and print channels and will be immediately incorporated into NPF programs activities.

Public health relevance
Project Narrative In support of the National Psoriasis Foundation (NPF)'s mission to drive efforts to cure psoriatic disease and improve the lives of those affected, the 2017 NPF Research Symposium will bring together more than one-hundred psoriatic disease researchers for a three-day scientific meeting in Chicago, IL. Through scientific sessions and discussions, researchers will share knowledge, provide updates on current research, and engage with patients. Goals from the meeting are to enrich the psoriatic disease research community and to shape the future for NPF research funding and activities.